Data Management Core B

SUMMARY – CORE B
This PPG competitive renewal proposes four projects that, together, seek to identify and characterize the
causes and consequences of inequity in the delivery of Alzheimer’s disease and related dementias (ADRD)
healthcare services. The Data and Analytics Core (Core B) is responsible for the comprehensive ADRD-
specific data management and analytic support required to design and execute these projects. To meet these
goals, Core B will create: (1) a comprehensive database with sufficient power to characterize detailed patterns
of healthcare utilization, (2) a broad array of measures drawn from diverse sources that can augment these
data, (3) the analytic capacity, expertise, and oversight to ensure timely, high-quality design and execution of
analyses and creation of analytic datasets, and (4) appropriate access to these resources for other
investigators including common definitions of ADRD, data repository of coded qualitative data, and a legacy
plan to ensure that the data curation is easily understood, accessed, and documented for future research. The
specific aims of Core B are: (1) To maintain a comprehensive and secure database of administrative data
including Medicare and Medicaid enrollment files, claims records, supplementary files, as well as qualitative
data as identified by each Project Leader; (2) To create shared resources and measures—including ADRD
cohort definitions, code libraries, and interview guides—for use across all projects; (3) To provide study design,
data collection, and data analysis technical support and analyst effort for quantitative and qualitative aims
across all four projects; and (4) In coordination with Core A, to make the research files developed under this
PPG available to the broader research and policy community, and to facilitate data triangulation across the four
projects. All four projects will interact with Core B in four ways. First, the projects will be responsible for
developing and testing new measures and methods that then become part of Core B’s repository for
production and dissemination among the investigators. Second, each project will use analytic datasets and
data collection, management, and analytic support created through Core B personnel. A major enhancement to
this renewal is the introduction of qualitative and mixed-methods data management and analytic support to
build upon existing methods (based on Medicare claims) and link to newer resources developed under this
renewal. Third, the leadership of Core B will be responsible for fostering a collaborative environment in which
analysts and investigators continue to work seamlessly to generate data and research of the highest caliber.
Finally, because of Core B’s involvement in all four projects, personnel will be able to leverage early- phase
methods and findings to help inform questions or triangulate with data collected in later phases across all
projects.